Host determinants of enterovirus RNA replication and in vivo neuropathogenesis

PROJECT SUMMARY
Pathogens have evolved to co-opt cellular functions to support their replication and spread while inactivating
innate immune mechanisms that restrict their growth. Discovery and characterization of cellular components that
regulate pathogenesis hold promise for revealing new approaches to treat infectious diseases. Enteroviruses
(EVs) comprise a large genus of single-stranded RNA viruses of positive polarity whose members cause a
number of important human diseases such as poliomyelitis, myocarditis, acute flaccid paralysis and the common
cold. How EVs co-opt cellular functions to promote replication and cause pathogenesis is incompletely
understood. Through robust, unbiased knockout screening approaches, we have discovered that the protein
methyltransferase SETD3 is required for infection by a broad range of human EVs. We showed that enterovirus
replication is severely hampered in human cells lacking SETD3 and that the block occurs during the RNA
replication step. SETD3 is a methyltransferase that mono-methylates actin, thereby regulating actin function.
However, we found that methyltransferase activity of SETD3 is not required for its role in viral replication
indicating that enteroviruses’ reliance on SETD3 is independent of actin methylation. We further showed that
SETD3 interacts with the viral nonstructural 2A protein of several enteroviruses. SETD3 is critically important for
in vivo pathogenesis as we show that Setd3-/- mice are completely protected from lethal intracranial inoculation
with EV-A71 in a neonate model. These findings demonstrate that SETD3 controls pathogenesis for a large class
of viruses with a strong impact on human health including non-polio EVs that can cause severe neurological
symptoms (EV-A71, EV-D68). In this application, we will determine the specific role of SETD3 in viral RNA
replication, structurally characterize the interaction between SETD3 and 2A, and test the hypothesis that
SETD3’s interactions with viral nonstructural proteins are a novel molecular mechanism by which EVs hijack
cellular machinery to enable genome amplification. Furthermore, to study the in vivo role of SETD3 in a mouse
model that recapitulates more faithfully the transmission cycle and pathogenesis of enteric enteroviruses, we will
develop and apply an oral infection model of EV-A71 in immune-competent mice. Our results will provide details
on the molecular mechanisms by which host factors promote enteroviral RNA replication, reveal how non-
catalytic functions of methyltransferases act in microbial pathogenesis and uncover the in vivo role of SETD3 in
promoting EV-A71 replication in diverse cell types involved in initial replication, systemic spread and ultimately
in neuropathogenesis.

Public health relevance
PROJECT NARRATIVE Enteroviruses are ubiquitous pathogens causing a number of important human diseases including poliomyelitis, myocarditis, acute flaccid myelitis and the common cold. Rhinovirus infections are a major cause of severe asthma exacerbations and non-poliovirus enteroviruses such as EV-A71 cause severe neuropathogenesis in children. Our contributions will have wide-reaching impacts as the identified cellular genes and molecular mechanisms are likely to provide new targets for therapeutic interventions, in addition to fundamentally advancing the fields of viral infection, immunity and protein methylation.